Core D: Genomics and Biomarker Core

CORE D: PROJECT SUMMARY
The Genomics and Biomarker Core has as its goal to contribute to a diverse ancestral Alzheimer disease (AD)
cohort by coordinating biospecimen receipt, storage, and tracking while creating genotyping and biomarker data
for downstream analyses. This core utilizes the combined specialized expertise, experience, and cutting-edge
technological and analytical methods at UM and CWRU. To accomplish these goals, the core has established
three specific aims that interact with and support other cores and both projects. These specific aims are: 1)
Prepare, store, track, and allocate high quality DNA, plasma, and PAXGEne RNA tubes from the newly
ascertained cohorts (N=5,000 individuals from African sites and 8,000 individuals ascertained from US sites);
2) Generate and perform quality control on genome-wide SNP array data for all collected samples and plasma
AD biomarkers including total Tau, A 40, and A 42, phospho-Tau181, and Neurofilament light on a subset of
900 individuals (300 Nigerian, 300 African American, and 300 Cuban); and 3) harmonize analytical pipelines with
pre-existing genotyping and biomarker data with newly generated genotyping and biomarker data for
dissemination through Core E to the projects and NIAGADS. In completing these aims this core plays a critical
role in bridging the ascertainment and data management cores and generates data for both projects and the
broader AD research community. Moreover, the biospecimens including extracted DNA, frozen plasma,
PAXGene RNA tubes will serve as a standing resource for future AD basic and translational research.